Cancer Center Support Grant

Abstract
Through this proposed new supplemental award, the UCLA Jonsson Comprehensive Cancer Center
Community Outreach and Engagement (JCCC COE) team will collaborate with community partners, the
Mixteco Indigena Community Organizing Project (MICOP) and Antelope Valley Partners for Health (AVPH) to
develop and disseminate tailored multi-channel communication campaigns to promote cancer screening and
tobacco control in predominately low-income Latinx communities in two high need regions served by the
JCCC. In keeping with Track 2 of this funding opportunity, campaigns will focus on the general population,
ages 30 and over, promoting breast, cervical and colorectal cancer screening, and raising awareness about
lung cancer screening. MICOP works to aid and empower the Indigenous immigrant agricultural community in
Ventura County, California. This community faces many obstacles to accessing health care, including linguistic
barriers as many community members speak only their native non-written languages. MICOP's radio station
broadcasts in Indigenous languages, providing an important means of imparting information to the community.
The Antelope Valley (AV) is one of the least densely populated and most economically challenged areas of Los
Angeles County, with relatively few health and social service resources. AVPH is a non-profit community
collaborative dedicated to improving the lives of underserved residents in the AV. Building on the successes
and lessons learned through our collaborative efforts in the ongoing UCLA MICEO supplement, and with
continued guidance from our Project Advisory Committee, we will craft, disseminate and evaluate messages
tailored to meet the specific needs and preferences of the communities served by our partner organizations.
We expect to reach a total of 78,500 community members, including 70,000 residents via MICOP's radio
station and via social media campaigns incorporating audio overlay in Indigenous languages and 8,500
residents through AVPH, via social media and community health worker outreach. We will track campaign
reach and numbers of residents who seek screening because of our campaigns. Brief surveys with community
members will assess cancer screening knowledge and awareness and interviews with clinic staff and
community health workers will examine which aspects of campaigns were most impactful. The JCCC COE
team has decades of experience collaborating with community organizations, including MICOP and AVPH. We
are eager to build on lessons learned in the first project year and will utilize the extended project period to craft
toolkits for each campaign, to support sustained implementation by our partners and widespread dissemination
to other local partners as well as via state and national networks. The proposed work is closely aligned with the
mission of the JCCC and COE to reduce cancer disparities through outreach and engagement activities in the
most affected communities.

Public health relevance
Narrative Through this supplemental funding award, the UCLA Jonsson Comprehensive Cancer Center Community Outreach and Engagement (JCCC COE) team will collaborate with community partners, the Mixteco Indigena Community Organizing Project (MICOP) and Antelope Valley Partners for Health (AVPH) to develop tailored multi-channel communication campaigns to promote cancer screening and tobacco control in predominately low-income Latinx communities in two high need regions served by the JCCC. Supplement activities are expected to reach over 78,500 residents and will include radio campaigns, social media campaigns, training of community health workers, and referral to cancer screening services. Receipt of this supplement will be instrumental in expanding our capacity to promote cancer screening and tobacco control in the high-need Latinx communities served by these organizations and to disseminate our messages and approaches more broadly.